Hermansky-Pudlak syndrome and melanosome formation

Lysosome-related organelles (LROs) are cell type-specific subcellular compartments that derive from the
endosomal system but that serve unique and vital physiologic functions. They include melanosomes in which
melanins are synthesized in skin melanocytes and in developing retinal pigment epithelial cells. The specific
functions of LROs are conferred by cell type-specific resident transmembrane proteins, such as melanogenic
enzymes and transporters, that are specifically targeted to newly forming LROs. Mutations in genes encoding
the cellular machinery responsible for this intracellular targeting underlie the Hermansky-Pudlak syndromes
(HPS), a group of genetic disorders in which defective LRO formation leads to several symptoms including
oculocutaneous albinism with its associated defective vision and skin and eye hypopigmentation. The known
isoforms of HPS result from mutations in genes that encode subunits of four obligate multisubunit complexes –
AP-3 and BLOC-1, -2, and -3 – that facilitate protein sorting and membrane remodeling to promote cargo
delivery from early endosomal intermediates to maturing melanosomes. We have shown that BLOC-1,
together with AP-3, the microtubule motor KIF13A, and additional partners, functions to generate recycling
endosome-like tubular transport carriers from early endosomes that extend along microtubules and transiently
fuse with maturing melanosomes to deliver their cargoes. BLOC-2 and the lipid phosphatidylinositol-4-
phosphate (PtdIns4P) function downstream of BLOC-1 to target the tubules to maturing melanosomes, but the
molecular function of BLOC-2 is not known. Moreover, the spatiotemporal relationship between each of these
complexes and PtdIns4P during tubule formation, extension, and targeting is not understood. Finally, it is not
known how the ubiquitous AP-3 and BLOCs are adapted in specific cell types to target the tubules to LROs
instead of for recycling. This competing renewal proposal seeks to fill these knowledge gaps using a
combination of live cell imaging, biochemical and electron microscopy approaches, together with genetic
manipulation in cultured melanocytes. If successful, our aims will establish new paradigms of tubular transport
from endosomes to melanosomes that will extend to additional LROs and to ubiquitous endolysosomal
compartments, identify potential targets of mutations in HPS patients who currently lack a molecular diagnosis,
and provide potential therapeutic insights for the more debilitating HPS symptoms. The aims are:
1. Test whether BLOC-1 and its interacting partners associate with membrane tubules during their
formation, extension, and/or tethering using live cell imaging coupled with electron microscopy analyses;
2. Test whether BLOC-2 and PtdIns4P regulate the dynamic association of tubular membrane transport
carriers with microtubules using live cell imaging, biochemical, and unbiased proteomic approaches;
3. Test whether RAB30 confers cell-type specificity in BLOC-1-dependent membrane carrier targeting
using knockout/ knockdown together with microscopy and biochemical analyses.

Public health relevance
Hermansky-Pudlak syndrome is a group of genetic disorders that are particularly common in Puerto Rico and are characterized by oculocutaneous albinism, excessive bleeding, and in many cases a fatal lung fibrosis and/or immune deficiency. The symptoms result from the failure to form certain specialized membrane structures, or organelles, within affected cell types. This proposal uses the melanosome, a target organelle within pigment cells, as a model system to understand how the products of the genes that are disrupted in Hermansky-Pudlak syndrome patients normally function together to generate specialized organelles.